Neuropathology Core

ABSTRACT
The major purpose of the Neuropathology Core (NP Core) is to perform diagnostic neuropathologic evaluations
on brains of participants in the Einstein Aging Study (EAS) and to provide research support for the Projects.
The NP Core integrates its activities with the neuropathology service at Montefiore Medical Center, led by Dr.
Steven S. Chin, who oversees the on-call service for harvesting brains in a timely fashion of subjects enrolled
in the EAS. The NP Core uses standardized dissection and processing procedures and collects
neuropathologic data on all brains. Diagnostic reports are provided to key personnel of the EAS as soon as
they are completed by electronic communication. Clinicopathologic correlation analyses are discussed at
annual meetings or through on-line virtual meetings using Zoom. The Specific Aims of the NP Core are as
follows: Aim 1. Perform brain autopsies and prepare tissue for transport from Montefiore Hospital to Mayo
Clinic. Aim 2. Perform diagnostic evaluations using a standardized and systematic approach that has been
used over the life of the EAS, permitting use of the entire autopsy cohort for clinicopathologic correlative
studies and for use in research studies. Aim 3. Enter data from the neuropathology report into an Access
database. Generate a written report for communication with clinicians and family members. Store a digital copy
on Mayo servers, with linkage to the NP Core database that is also linked to tissue inventory, ancillary data
(e.g., genetic data), as well as quantitative pathology and demographics, which permits pooling of Einstein
Aging Study cases with larger clinicopathologic studies. Neuropathologic data are transferred to Biostatistics
and Data Management Core. Aim 4. The NP Core will support exploratory studies in support of Projects, such
as correlations with antemortem biomarkers and assessment of neuroinflammation and pollutants in brain
tissue. The NP Core collects measures of cerebrovascular pathology, including microvascular and white matter
pathology, which can be used to explore pathologic relationships to cardiovascular measures. The NP Core
has tools to assess advanced glycation end products in the brain as a possible correlate of glycemic control.
Aim 5. Sharing of tissue. The Neuropathology Core banks fixed and frozen brain tissue, as well as paraffin
blocks on all cases. DNA and RNA are extracted from tissue. Fixed and frozen tissue, as well as DNA, slides
and paraffin blocks are available for sharing with qualified investigators with approval of the Administrative
Core.

Public health relevance
NARRATIVE A definite diagnosis of neurodegenerative disorders, such as Alzheimer’s disease, is only possible at autopsy, which also permits collection of brain tissue that can be used for research. The Neuropathology Core collects brain tissue on participants in the Einstein Aging Study for both diagnosis and to promote research on neurodegenerative disorders of the elderly.